Targeting PARP Proteins in electronic cigarettes-induced cardiac dysfunction

Project Summary:
Electronic cigarettes (e-cigarettes) are becoming exceptionally popular in the world as an alternative to
conventional cigarettes. Nicotine can induce lipolysis, leading to increased serum free fatty acids (FFAs).
Increased levels of FFAs are one of the key elements in inducing lipotoxicity, mitochondrial dysfunction, and
DNA damage. NAD+ homeostasis is regulated by nutrient-sensing signaling and DNA damage response
pathways, which play key roles in metabolism and survival. Poly (ADP-ribose) polymerases 1 (PARP1) and
Sirtuin-1 have a common co-factor, NAD+. Therefore, increased PARP1 activity can impact Sirtuin-1 activity by
reducing the NAD+ pool. We investigated the effects of acipimox, an antihyperlipidemic drug, on e-cigarettes-
induced cardiac dysfunction. C57BL/6J wild-type mice on high fat diet were exposed to saline, e-cigarettes with
nicotine (2.4%) [e-cig(2.4%)], e-cigarette (2.4%) plus acipimox, for 12 weeks. Fractional shortening and ejection
fraction was decreased in mice exposed to e-cig(2.4%) compared with saline and acipimox. Therefore, acipimox
rescued the e-cigarette-induced cardiac dysfunction. Transcriptomic evaluation with Gene Set Enrichment
Analysis revealed that e-cigarette-treated mice had genes enriched in the G2/M DNA damage checkpoint
pathways. These changes were normalized by acipimox. Mice exposed to e-cigarettes have increased circulating
levels of inflammatory cytokines, and FFAs which were regularized by acipimox. Moreover, mice exposed to e-
cig(2.4%) had increased apurinic/apyrimidinic sites and PARP1 activity. These manifestations of DNA damage
were normalized by acipimox. Aim 1 will test the hypothesis that PJ34, a potent inhibitor of PARP proteins,
reverses oxidative stress, mitochondrial abnormalities, and cardiac dysfunction induced by e-cigarettes. Aim 2
will elucidate if genetically increasing SIRT1 levels in cardiomyocytes can prevent the development of e-
cigarette-induced cardiac dysfunction. Aim 3 will assess the role of lipolysis on e-cigarette-induced cardiac
dysfunction with an inhibitor of adipose triglyceride lipase, atglistatin. PARP1 pathway might be a useful
therapeutic target to counteract the detrimental cardiac effects of e-cigarettes. Understanding the consequences
of e-cigarettes use on cardiac dysfunction and DNA damage response is directly relevant to the development of
policies related to tobacco use. As an R16 application, this project will strengthen the research environment at
Charles Drew University, a predominantly disadvantaged minority-serving Institution in the South Los Angeles
Area.
1

Public health relevance
Project Narrative: In recent years, electronic cigarettes (e-cigarettes) use by youth has increased at a disturbing rate. We have shown that e-cigarettes induce cardiac dysfunction associated with DNA damage in a mouse model. In this R16 grant application, we are proposing to determine the effects of e-cigarette induced DNA damage and ultimately aid in developing effective medical therapies to prevent e-cigarette-induced cardiac dysfunction.